ROLE OF FEMALE REPRODUCTIVE HORMONES IN ETIOPATHOGENESIS OF TMJ DISEASE

The purpose of studies is to elucidate the role of female reproductive hormones relaxin, estrogen & progesterone in the etiopathogenesis of TMJ disease in women. We plan to determine association of relaxin, b-estradiol & progesterone with symptoms of TMJ disease in women using a case control study design. We also will determine if salivary levels of relaxin, b-estradiol & progesterone correlate with serum levels these hormones. We will assess if changes in relaxin, b-estradiol & progesterone over short period of time during pregnancy predispose to TMJ disease. We will evaluate, by a longitudinal prospective study design, whether aberrations in levels of relaxin, b-estradiol & progesterone during puberty and early adulthood are assoicated with the onset of TMJ disease.